A Multimodal, Multiscale and Multistage Systems Biology (M3SB) Infrastructure for Precision Medicine in Alzheimer’s Disease and Longevity

PROJECT SUMMARY
Alzheimer’s disease (AD) and AD-related dementia (ADRD) are a major global health challenge, and the number
of affected individuals is expected to double by 2050, affecting more than 130 million people worldwide. Despite
this progress in understanding AD genetic risk factors, the complex, polygenic, and pleiotropic genetic
architecture has precluded the development of new therapeutics. This is partly because the growing mass of
genetic, multi-omics (such as genome, transcriptome, proteome and human interactome) and real-world patient
datasets has not been effectively explored for AD/ADRD drug development and patient care by lack of accurate
computational disease models. Our preliminary experiments demonstrated that systematic identification and
characterization of underlying aging biology (including inflammatory age [iAge] and PhenoAge Clocks), genetic
factors and real-world evidence will serve as a foundation for identifying and validating disease-modifying targets
and treatment for aging and AD/ADRD. We therefore posit that a Multimodal (genomics, transcriptomics,
proteomics, metabolomics, interactomics, radiomics, and real-world evidence), Multiscale (cross-species
interactome and celluome-wide), and Multistage (disease progression and endophenotypes), transformative
Systems Biology infrastructure (M3SB), enables more complete mechanistic understanding of aging
pathobiology and the rapid development of disease-modifying interventions for AD/ADRD and longevity with
great success. Aim 1 will conduct multi-modal analyses of ethnically diverse genetics, multi-omics data, cross-
species protein interactome networks, and human brain-specific functional genomic data to identify BioAge-
modifying targets and repurposable medicine for AD/ADRD. Aim 2 will test inflammatory aging (iAge) and
PhenoAge clock hypotheses involved in AD/ADRD pathogenesis and disease progression using longitudinal
fluid biomarkers, neuroimaging, and electronic health records (EHRs) data. Specifically, we will build both iAge
and PhenoAge clocks derived from longitudinal fluid biomarkers, neuroimaging, and laboratory testing from both
Cleveland and Indiana University Alzheimer’s Disease Research Centers, and deep real-world phenotypic data
available at the Marketscan (130 million patients), OPTUM (80 million patients), Indiana Network of Patient Care
(6 million patients), and Cleveland Clinic EHR databases (11 million patients). Aim 3 will test and validate
candidate iAge- and PhenoAge-derived repurposable treatments using patient iPSC-derived neurons and brain
organoids in conjunction with transgenic animal models. This comprehensive experimental validation aim will
identify mechanistic biomarkers linked to BioAge- and PhenoAge clocks to maximize efficacy for future precision
medicine-based AD/ADRD clinical trials. The successful completion of this M3SB project will build disease-
agnostic biomedical research and create flexible, accurate and interpretable computational models and
toolboxes under the FIAR data principles to incorporate multi-modal biomedical data to better categorize disease
complexity and produce interpretable patterns and insights for Alzheimer’s precision medicine.

Public health relevance
Project Narrative Alzheimer’s disease (AD) and AD-related dementia (ADRD) with complex biology, are devastating neurodegenerative conditions that are estimated to affect 16 million Americans and 130 million people worldwide by 2050. This project will create an integrative and customizable, Multimodal (genomics, transcriptomics, proteomics, metabolomics, interactomics, radiomics, and real-world patient databases), Multiscale (cross- species protein interactome and celluome-wide), and Multistage (disease progression and endophenotypes), transformative Systems Biology infrastructure (M3SB) for more accurate molecular characterization of aging pathobiology (including inflammatory aging (iAge) and PhenoAge clocks) and identifying effective treatment for AD/ADRD. The successful completion of this project will build disease-agnostic systems biology research and create flexible, accurate and interpretable computational disease models and toolboxes under the NIH FAIR (Findable, Accessible, Interoperable, and Reusable) data principles to incorporate multi-modal biomedical data in order to better categorize disease complexity and produce interpretable patterns and insights for Alzheimer’s target discovery and therapeutic development.